Interdisciplinary Training in Genome Sciences

ABSTRACT
We request funds to continue the Interdisciplinary Training Program in Genome Sciences at the University of
Washington, now in its thirtieth year. The program focuses on preparing pre- and postdoctoral trainees for a
research career in genomics and computational biology with an emphasis on translational research. We have
been delighted by the wide spectrum of talented individuals this program has attracted to genomics research,
and the continued success of these individuals is the best evidence of our program’s effectiveness. Past
trainees have written on average ~4 papers (~2 as first author), many of which are exceptionally impactful and
have altered the research trajectories of their labs, this program, or their broader fields. The overwhelming
majority of past trainees have remained in science careers, and ~40% of postdoctoral trainees currently hold
faculty positions. In the coming five years, our program’s trainees will engage in projects that include
discovering how a genome encodes the information for RNAs, proteins and its own structure and replication;
measuring and analyzing sequence variation; developing technologies for high-throughput experimental
assays including-next generation and single-cell sequencing; and generating computational methods, including
advanced AI tools, to analyze genomic variants and their impact on mRNA and protein function. As these
research challenges demand interdisciplinary approaches and multidisciplinary collaborations, one goal of this
program is to attract individuals trained in computer science, statistics, physics, and engineering to biological
research. Another goal is to train cellular and molecular biologists to incorporate reproducible, genomic-based
quantitative analyses in their research to allow them to effectively collaborate at this interdisciplinary interface.
Given the wide diversity in educational backgrounds and career goals among our trainees, the program
emphasizes highly individualized training programs and interdisciplinary research. A diverse, well-funded,
multidisciplinary group of 49 faculty drawn from the ranks of junior to senior investigators comprises the
training team, selected for their involvement in genome analysis and their strong record of collaborative
interactions. The trainees are also exposed to discussions on ethical research conduct and the ethical, legal,
and social implications of genomic research. We will continue to expand our program in genomics,
instrumentation development, data science, computational biology, and statistical genomics. We request funds
to train 12 predoctoral and 4 postdoctoral fellows per year. The trainees will emerge with the skills necessary
for success in the academic and biomedical research environment of the 21st century made possible by
advances in genomics.

Public health relevance
NARRATIVE Genomics is integral to modern biomedical research and diagnosis. Genome-wide studies are used to identify potential genetic causes of disease and investigate fundamental questions of biology and development. Our program will train pre- and postdoctoral trainees for future biomedical and interdisciplinary research in genomics and computational biology.